MOdeling Nursing homes to Affect Response to COVID-19 (MONARC)

PROJECT SUMMARY ABSTRACT
Nursing homes have been hit particularly hard by the severe acute respiratory syndrome coronavirus 2
(SARS-CoV-2) pandemic. NHs may serve as epicenters of transmission that could continue to help fuel the
overall pandemic because they are critical parts of complex, interconnected networks of health facilities in a
region. However, determining how best to prevent/control the transmission of SARS-CoV-2 in nursing homes
can be challenging. A NH itself is a complex system, consisting of NH residents/staff/visitors that mix with each
other in different ways throughout a given day. Since NHs and the ecosystems that they sit within are complex
systems, computational modeling that integrates economic, operational, and epidemiologic aspects of SARS-
CoV-2 can provide decision makers with important insights on how best to prevent the spread of SARS-CoV-2
within NHs and throughout the surrounding region. The overall goal of this proposed project, MOdeling
Nursing homes to Affect Response to COVID-19 (MONARC), is to develop agent-based models (ABMs)
of the 70 NHs in OC and use these models to help design and evaluate various SARS-CoV2 policies
and interventions (e.g., screening, testing, and cohorting strategies for NH residents, NH staff and
visitors). Furthermore, the project will develop a new computational tool that NH administrators and
public health officials and policymakers in other regions can then use to build models of their NHs to
use to make decisions about COVID-19 prevention and response. This project will be led by two seasoned
investigators and their teams who have worked together for over a decade on developing ABMs to
prevent/control the spread of infectious diseases in healthcare facilities. Since 2007, this has included helping
decision makers address nearly every major infectious disease threat to the U.S., including being embedded in
Health and Human Services (HHS) during the 2009 H1N1 epidemic. This project will be a natural extension of
our past projects and our current COVID-19 coronavirus modeling work. Specific Aim 1 will develop ABMs of
the 70 NHs in OC to evaluate the impact of different SARS-CoV-2 symptom screening and COVID-19 testing
strategies such as the timing, frequency, and test types. Specific Aim 2 will explore the value of various
strategies to cohort COVID-19-positive NH residents and the staff who care for them, within and across
different NHs. Specific Aim 3 will develop a computational tool that can simultaneously evaluate symptom
screening, testing, and cohorting strategies to address COVID-19 in NHs, accounting for local prevalence,
facility size, and adherence to infection prevention standards. The MONARC project will bring multiple
innovations including: 1) addressing urgent but currently unaddressed questions about what NHs can do to
prevent/control the spread of SARS-CoV-2, 2) determining how SARS-CoV-2 prevention and control strategies
should be tailored by different NHs and NH resident and staff characteristics and 3) developing a
computational tool that NHs can use to help determine the best strategies in response to SARS-CoV-2.

Public health relevance
PROJECT NARRATIVE Nursing homes (NH) have been hit particularly hard by the severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) pandemic and may serve as epicenters of transmission that could continue to help fuel the overall pandemic. The overall goal of this proposed project, MOdeling Nursing homes to Affect Response to COVID-19 (MONARC), is to develop agent-based models (ABMs) of the 70 NHs in OC, use these models to help design and evaluate various SARS-CoV2 policies and interventions, and develop a computational tool that NH administrators and public health officials and policymakers in other regions can then use to build models of their NHs to use to make decisions about COVID-19 prevention and response.